Optimizing a Social Connectedness Intervention for Young Adults with Cancer

PROJECT SUMMARY/ABSTRACT
Young adults with cancer need tailored behavioral interventions to improve their psychosocial health. Any
cancer diagnosis in early adulthood can create debilitating life disruptions that increase social isolation that in
turn can compromise psychosocial health. Social isolation also predicts mortality comparably to other well-
established risk factors, including tobacco use, excessive alcohol consumption, obesity, and sedentary status.
This conclusion—described as “unequivocal”—was established by a large-scale meta-analysis and now fuels
the call for low-cost and scalable behavioral interventions optimized for vulnerable populations to increase
social connectedness. The demand for such interventions is especially pressing for young adults with cancer,
whose unique needs have long gone unmet. The broad, overarching objective of this work is to optimize an
evidence-based social connectedness intervention for young adults with cancer and test whether it improves
their psychosocial health. This intervention, delivered digitally and effective among young adults (noncancer
samples), prompts individuals to increase the emotional quality of their in-person social encounters. Our multi-
disciplinary team will carry out a rigorous, randomized controlled trial—the Keep Social RCT—using our
simulated social media platform to deliver intervention messages optimized for young adults with cancer while
collecting repeated measures of day-to-day experiences and psychosocial health outcomes. This program of
research is designed to meet three specific aims. SPECIFIC AIM 1 is to optimize our social connectedness
intervention for young adults with cancer. This aim will be met using a human-centered communication science
approach to enhance the positive reception of health messages with social context cues (human imagery, peer
stories), and conduct an online experiment with 400 young adults with cancer to identify the most effective
intervention messages for use in the Keep Social RCT. SPECIFIC AIM 2 is to pilot, conduct, and analyze the
Keep Social RCT to test whether our social connectedness intervention, delivered via social media, improves
psychosocial health in young adults with cancer. After thorough pilot testing, this aim will be met by conducting
our placebo controlled Keep Social RCT with repeated assessments over six weeks. These data will allow us
to test whether our intervention raises social and emotional well-being (primary outcomes) and improves
resilience and negative mental health symptoms (secondary outcomes). SPECIFIC AIM 3 is to extend data
analyses of the AIM 2 Keep Social RCT to test theory-based mechanisms and explore moderators of
intervention effectiveness to pave the way for further optimization. This aim will be met with statistical modeling
to identify how and for whom our social connectedness intervention improves psychosocial health among
young adults with cancer. Our multi-disciplinary team brings together expertise in social psychology, emotion
science, communication science, and oncology to pursue these aims to produce translation-ready pragmatic
knowledge to improve the quality of life among young adults with cancer in the United States.

Public health relevance
PROJECT NARRATIVE Social isolation is common among young adults with cancer, which can compromise their psychosocial health. We propose to optimize an evidence-based social connectedness intervention for young adults with cancer and conduct a randomized controlled trial to test its efficacy to improve psychosocial health in this population. This research leverages a highly scalable behavioral intervention to address the unmet psychosocial needs of young adults with cancer.